Information encoding by spatiotemporal patterns of dopamine release

Project Summary
The activity of midbrain dopamine (DA) neurons, and bulk DA release in the ventromedial striatum (VMS),
encodes reward prediction errors (RPE). However, there is also evidence that DA activity reflects value-
orthogonal aspects of learning, including value-less sensory prediction errors (SPE). Reconciling these two
bodies of data would greatly advance our understanding of DA transmission in normal and pathological
conditions.
One proposition is that DA release might signal a multi-factorial prediction-error. This would explain recent
findings demonstrating that DA neuron ensembles encode the sensory properties of outcomes that violate
learned predictions. This requires that this information, observable at the level of neuronal firing, be transmitted
to downstream regions via DA release. This proposal will test the hypothesis that DA neurons encode a multi-
dimensional error signal by examining specific spatiotemporal patterns of DA release in downstream regions.
The current proposal takes advantage of a new methodological approach that I developed during my postdoc to
image DA release in freely moving rats across a wide area at cellular resolution, as well as new technologies for
gene editing and neuronal manipulation. Rats will perform an odor-guided choice task that induces both RPEs
and SPEs, while DA release in the VMS will be recorded using dLight1.2 combined with GRIN lens implants and
the UCLA miniscope. These recordings will be analyzed with machine learning algorithms to determine whether
the specific spatiotemporal pattern of DA release encodes both value-based and value-orthogonal information
(Aim 1). It will also be examined if these signals may be degraded in a pathological condition, by performing
recordings in rats with chronic cocaine use experience (Aim 2). For the independent phase of the proposal, I will
first examine the role of upstream cortical circuits in the encoding of this information by using chemogenetics to
silence the orbitofrontal cortex (OFC) (Aim 3). I will then focus on how a specific biophysical property of DA
neurons may shape this information encoding, by using gene editing techniques to delete a key K+ modulator in
DA neurons while imaging DA signals in the proposed task (Aim 4).
During the mentored phase of the current proposal, I will receive training critical for my short- and long-term
success, including analysis of high-dimensional neural data, genetic editing using CRISPR-Cas9, and rodent
self-administration models of drug use. The proposed training program combines hands-on training with expert
experimenters, independent study, formal coursework, establishment of an independent collaboration, and
professional scientific meetings. This program will equip me to lead a laboratory focused on the interaction of
behavioral, computational, and molecular approaches to study the function of neural circuits.

Public health relevance
Project Narrative Midbrain dopamine (DA) neurons were classically thought to homogeneously encode reward prediction errors, but recent evidence has demonstrated that they also encode other behavioral variables, including value-neutral sensory prediction errors. Reconciling foundational concepts and these recent findings, as well as with what is known about the cellular properties and circuit connectivity of DA neurons, is currently one of the key challenges in the field. This project combines a validated odor-guided choice task with a new DA imaging approach developed by the candidate, as well as drug self-administration, chemogenetic, and gene editing methods, to test the hypothesis that spatiotemporal patterns of DA release encode a multi-factorial prediction-error teaching signal, and that the informational components of this signal are vulnerable to pathophysiological challenges, depend on the contribution of upstream cortical circuits, and are shaped by specific biophysical properties of DA neurons.